PHASE III STUDY TO EVALUATE THE SAFETY AND EFFICACY OF EARLY DDC PLUS ZDV

This study evaluates the safety, tolerance and activity of dideoxycytidine (ddc) plus zidovudine (ZDV) as compared to zidovudine alone in stable, ZDV treated children with HIV infection.